Extracellular Matrix Adhesins of Treponema pallidum

Project Summary/Abstract
Syphilis remains a public health threat worldwide, with an estimated 11 million new infections per year and a
global burden of 36 million infections. Within the last decade there have been outbreaks of syphilis cases in
major cities around the world, including within the United States, Canada, Europe, Australia and China. A
particularly sharp increase has been observed in men who have sex with men, with an alarming 56%
increase observed since 2011. Syphilis infections increase the risk of acquiring and transmitting HIV, and
there has been an 88% increase in congenital syphilis infections, resulting from mother to child transmission
in utero, within the United States since 2012. Although syphilis is curable with penicillin treatment if
diagnosed early, the worldwide syphilis prevalence shows that elimination of this disease will not occur
through public health control measures alone, and instead will require development of effective strategies to
prevent infection with this pathogen.
Development of infection prevention strategies requires an in depth knowledge of the pathogenic
mechanisms used by this highly successful pathogen. The bacterium that causes syphilis, Treponema
pallidum, is able to disseminate rapidly within the host during the early stages of infection to infect every
organ and tissue. Minimal understanding exists surrounding the pathogenic mechanisms used by T.
pallidum to undergo widespread dissemination throughout the host, and gaining understanding within this
highly relevant area of study will reveal novel vaccine candidates that can be targeted to prevent
establishment of infection.
The long-term objective of the studies contained in this proposal is to guide effective syphilis vaccine design
by increasing our understanding of the pathogenic mechanisms used by T. pallidum to cause disease. To
accomplish this objective, the following specific aims are proposed: (1) to investigate the interaction of the T.
pallidum adhesin Tp0751 with the host endothelial proteins laminin receptor (LamR), stomatin, and
epidermal growth factor-containing fibulin like extracellular matrix protein 1 (EFEMP1), which were identified
as Tp0751-binding targets during the current funding period, as well as to investigate the interaction of T.
pallidum with the endothelial receptor platelet activating factor receptor (PAFr) which is hypothesized to play
a role in pathogenesis due to parallels with other invasive pathogens; (2) to determine the host endothelial
cell signaling pathways activated by Tp0751 and T. pallidum to facilitate treponemal dissemination; and (3)
to determine the functional consequence of Tp0751/T. pallidum engagement with host endothelial cells, at
both the whole cell and molecular levels. These studies will increase understanding of the critical process of
T. pallidum dissemination and are expected to reveal a novel pathogenic strategy of host signaling
subversion used by T. pallidum to enable crossing of cellular barriers and accessing of deeper tissues within
the host.

Public health relevance
Project Narrative Syphilis infections continue to be prevalent worldwide, with an estimated global burden of 36 million cases and recent outbreaks observed in North America, Europe and Asia. The bacterium that causes syphilis is one of the most invasive organisms known, and this research investigates how the bacterium is able to spread so widely and rapidly within the host. This research will increase understanding of how the bacterium causes infection and will allow development of strategies to prevent syphilis infection.